Apoptotic neuronal cells serve as sources for spreading of human a-synuclein pathology in the brain

PROJECT SUMMARY Human α-Synuclein (hαS) aggregation is considered as a primary mechanism of neurodegeneration in Parkinson's Disease(PD). Accordingly, the theory of cell-to-cell propagation of hαS aggregates is well- accepted, as it can reasonably explain progressive propagation of hαS pathology and associated neuronal degeneration in PD. On the other hand, the theory does not account for trigger for hαS aggregation. Our recent study suggested that one possible explanation for initial hαS aggregation in PD and related disorders may be disruption of nuclear membrane integrity, as occurs during apoptosis. This exposes cytoplasmic hαS to proaggregant nuclear factors, which remain to be determined, but could include histones. Aggregates released in the immediate vicinity of the affected neurons may template hαS in nearby neurons that may then spread by cell-to-cell propagation, leading to more distant neurodegeneration. Conditions that limit clearance of apoptotic bodies (e.g., age-associated declines in immune competence) would be predicted to accelerate the process. Accordingly, pathological hαS might be at least, in part, a secondary phenomenon associated with loss of nuclear membrane integrity or neuronal apoptosis instead of primary event in the pathogenic cascade of PD. It remains to be seen if abnormal conformers of hαS may compromise nuclear membrane integrity. In our previous study in support of our hypothesis, we have exogenously inoculated mice brains with hαS aggregates generated from apoptotic neuronal cultures to test neuronal uptake in vivo. In this proposal, we will introduce the herpes simplex virus thymidine kinase(HSVtk)/ ganciclovir(GCV) system, a well- established strategy for drug induction of cell apoptosis in cancer therapy, to PD research for the first time and perform stereotaxic brain injection of lentivirus into bilateral substantial nigra (SN) of a mouse line to overexpress both HSVtk and Myc-hαS via lentivirus infection. The animals are from a human αS transgenic mouse line without any observable pathology throughout the life cycle. Upon GCV administration, this mouse model is expected to self-generate transmissible filamentous Myc-hαS aggregates whose spreading can be tracked by histologically detecting Myc tag. We will investigate in vivo how the initial self-generated Myc-hαS aggregates seed subsequent aggregation of normal non-pathological hαS and whether such propagation of hαS pathology can cause further neuron loss beyond the SN regions. To our knowledge, this PD mouse model will be the first one able to conditionally generate transmissible filamentous hαS aggregates for spatio- temporally tracking propagation of hαS aggregates originated in SN regions. We expect that this study can provide more direct evidence to support our hypothesis, and Braak staging theory as well.

Public health relevance
PROJECT NARRATIVE In this proposal, we will establish a mouse model to investigate in vivo how the initial self-generated human α- Synuclein(hαS) aggregates in substantia nigra (SN) seed subsequent aggregation of normal non-pathological endogenous hαS and whether such propagation of hαS pathology can cause further neuron loss beyond the SN. To our knowledge, this PD mouse model will be the first one able to conditionally generate transmissible filamentous hαS aggregates for spatio-temporally tracking propagation of hαS aggregates so as to provide direct experimental evidence to confirm our hypothesis about the role of apoptosis as initial sources of pathological hαS, which will be relevant to understanding pathogenesis of PD and testing the Braak staging hypothesis for PD progression after involvement of the SN.